Improving accessibility and efficacy of in vivo forward genetic screening

Abstract
The advent of fast and affordable sequencing technologies has facilitated detailed descriptive annotation of
many mammalian genomes. In contrast, functional annotation connecting genetic variants to phenotypes is
severely lacking, due to an inability to conduct current methods at scale. Removing this bottleneck will facilitate
rapid identification and characterization of key regulators of physiological and disease processes, which is
necessary for the development of targeted therapeutics. Methodologies based on high-throughput functional
genomics offer a rapid, affordable, and systematic way to characterize gene functions, with CRISPR-based
pooled forward genetic screens being one such method, which has been used to great effect in cultured cells.
However, due to multiple barriers, the in vivo application of forward genetic screens has thus far been
extremely limited, hindering our ability to study tissues that cannot be adequately modeled in vitro, such as the
heart and brain. In this work, we assess the obstacles hindering extensive adoption of forward genetic screens
in vivo and propose innovative techniques to overcome these challenges. We will utilize the heart for proof-of-
concept studies that will examine regulation of Nppa, a gene encoding the cardiovascular disease biomarker
atrial natriuretic peptide (ANP). Our methodologies can be adapted to many tissues and will provide significant
value to diverse research initiatives.
Furthermore, we propose a groundbreaking in vivo forward genetic screen for regulators of cellular proliferation
– a critical biological process relevant to a wide variety of fields such as cancer biology, development, and
tissue regeneration. By merging several cutting-edge technologies, our strategy will enable efficient
identification of regulators of cardiomyocyte proliferation. This study, which is currently not possible using
conventional screening methods, will serve as a blueprint for employing systematic functional genomics in
tissues that are difficult to model in vitro or to deliver molecular components to in vivo. In sum, successful
execution of the strategies described in this proposal will considerably reduce the level of expertise and
resources that are required to take advantage of the unbiased systematic nature of in vivo forward genetic
screens, leading to the improvements in functional annotation of the genome that are necessary to inform the
design of therapeutics.

Public health relevance
Project Narrative The development of therapies for genetic disorders is currently limited by our incomplete understanding of the roles played by individual genes across development and during disease. These limitations are due in large part to the difficulties of measuring phenotypes associated with genetic perturbations at scale. In this proposal, we assess the obstacles preventing extensive in vivo adoption of CRISPR-based forward genetic screens in mammalian model organisms and present a plan to overcome these challenges using novel functional genomics-based approaches.